Ethnographic investigation of factors affecting conceptualization and provision of social prescribing in outpatient primary care clinics in the United States

Project Summary/Abstract
The proposed fellowship plan is an interdisciplinary research project integrating training in anthropology,
medicine, and implementation science. This project is supervised by Drs. Adrienne Strong, Clarence Gravlee
(Dept. of Anthropology), Ramzi Salloum (Dept. of Health Outcomes and Bioinformatics), and Grant Harrell
(Dept. of Community Health and Family Medicine) with the resources and support of the University of Florida
(UF) College of Liberal Arts and Sciences, the UF College of Medicine and the UF Clinical Translational
Sciences Institute. The proposal is designed to equip the trainee with the skills necessary to become a
physician-scientist who bridges the divide between the social sciences and clinical medicine. Social
Determinants of Health (SDH) are known to impact a wide array of physical and mental health outcomes.
However, little is known about how physicians identify and interpret patient social information, and act upon
this information in support of their patient’s health and wellbeing. This proposal will focus on US outpatient
primary care clinics for two reasons: primary care prioritizes holistic well-being of patients through the life
course and there has been a significant push in recent years to incorporate SDH interventions into primary
care clinics. Previous investigations have focused primarily on development of screening tools and limited
interventions focused on special populations or specific SDH. Such investigations pay little attention to the
informal methods providers and primary care clinics have developed to identify and address clinically relevant
social conditions in day-to-day practice, activities here collectively termed “social prescribing”. Thus, an
investigation grounded in interdisciplinary health services and implementation science literature, with an
exploratory component to allow for the description and analysis of these as yet uninvestigated practices and
beliefs relating to social prescribing is warranted. The overarching hypothesis is that patient, provider, and
clinic level factors affect primary care provider conceptualization and implementation of social prescribing
practices. The specific aims will lead to greater understanding of knowledge translation of social science
research to clinical medicine in primary care through (1) identification of factors affecting social prescribing
conceptualization among diverse primary care providers and (2) identification of factors affecting social
prescribing implementation among diverse primary care providers. Successful completion of these studies will
enhance understanding of factors affecting development, implementation, and outcomes of social prescribing
interventions across diverse care contexts. This research directly targets multiple Clinical and Health Service
Research Interest Areas defined by the National Institute of Minority Health and Health Disparities.

Public health relevance
PROJECT NARRATIVE Social Determinants of Health have repeatedly been shown to have a significant impact on physical and mental health outcomes and may be a key driver of population level health disparities. This investigation seeks to understand how primary care providers understand, evaluate, and seek to address these social conditions in the outpatient primary care context. The overarching goal is to improve primary care management of patients with complex social conditions in such a way that appreciates and addresses the influence of multiple factors on the provision of social care in the clinical setting.